Core Vision Grant - Neuroanatomy

Abstract
The Neuroanatomy Module provides essential support for the Vision Core in three main areas: 1) Histological
and immunohistochemical tissue processing; 2) Anatomical imaging, data acquisition and image analysis; 3)
Preparation of viral vectors for optogenetic manipulation of neuronal signals.
The Neuroanatomy Module provides moderate or extensive support for 13 members of the Vision Core,
including one young investigator and 7 NEI funded investigators holding qualifying R01 grants.